Dissecting roles of microbiome-host interactions in colorectal neoplasia etiology using multi-omics data

PROJECT SUMMARY
Microbiome dysbiosis has been increasingly recognized to be associated with colorectal neoplasia, including
colorectal adenoma and colorectal cancer (CRC). Disturbances of the gut microbial community, as well as the
presence of specific gut microbes, such as Fusobacterium nucleatum and Bacteroides fragilis, have been
linked to the initiation and progression of colorectal neoplasia. Meanwhile, aberrant DNA methylation and gene
expression patterns are hallmarks of colorectal neoplasia. Hence, to establish a direct and causal link between
the gut microbiome and colorectal neoplasia, it is crucial to determine whether and how the gut microbiome
affects the DNA methylome and transcriptome in colon tissues. A well-designed population-based study
investigating microbiome-host interplays would shed new light on the etiology of colorectal neoplasia. During
the past ~20 years, my mentor's team has established two large population-based studies, the Tennessee
Colorectal Polyp Study (TCPS, part of the P50CA95103, PI: Zheng) and the Southern Community Cohort
Study (SCCS, U01CA202979, PIs: Blot, Zheng and Shrubsole). Herein, I propose a multi-omics study
leveraging the unique resources from these large studies to systematically evaluate the impact of the gut
microbiome on DNA methylome and transcriptome in human colorectal neoplasia. In the K99 phase, for Aim
1, I will investigate the associations of microbiome with DNA methylation and gene expression in colorectal
adenoma tissues (N=200). For Aim 2, I will evaluate the mediatory roles of microbiome on the associations of
known CRC risk factors, such as obesity and unhealthy dietary patterns, in association with DNA methylation
and gene expression in colorectal adenoma tissues (N=200). In the R00 phase, for Aim 3, I will further
evaluate the findings from the K99 phase in additional colorectal adenoma tissues (N=439) and search for
novel associations and mediations through combining all data of colorectal adenoma tissues (N=639). In
addition, the findings in colorectal adenoma tissues will be investigated in CRC tumor tissues (N=96). For Aim
4, I will prospectively investigate the relationship of the pre-diagnostic gut microbiome with DNA methylation
and gene expression in colorectal adenoma tissues (N=139) and CRC tumor tissues (N=96), as well as with
risks of colorectal adenoma (139 cases and 139 matched controls) and CRC (96 cases and 96 matched
controls). Finally, these results will be integrated to identify potential pathways through which the microbiome
might impact colorectal neoplasia. The findings will improve our understanding of how the microbiome-host
interactions impact colorectal neoplasia development and have translational potential to develop new tools for
CRC prevention. The proposed career development award will help me gain advanced knowledge of
epidemiology, CRC biology, microbiology, advanced bioinformatics and biostatistics, as well as skills in
mentoring and educating students and junior fellows, for my transition to a successful independent investigator.

Public health relevance
NARRATIVE It has been increasingly recognized that the gut microbiome is associated with colorectal neoplasia; however, the carcinogenesis mechanisms are not clear. This is the first large population-based study that utilizes a multi- omics approach to investigate microbiome-host interplays in the etiology of colorectal neoplasia. The findings will improve our understanding of how microbiome-host interactions impact the development of colorectal neoplasia and have translational potential to develop new tools for CRC prevention.